Project 3: The ATM Kinase as a Therapeutic Target in Drug Resistant NSCLC with Brain Metastasis

PROJECT SUMMARY
Patients with non-small cell lung cancer (NSCLC) and multi-organ metastases have worst prognosis. NSCLC
brain metastases remain challenging to treat, as they can progress despite initialing responding to blood-brain
barrier (BBB) penetrant targeted therapies or immune checkpoint blockade (ICB). The ataxia-
telangiectasia mutated serine/threonine kinase (ATM) is a canonical regulator of DNA damage response
(DDR). However, ATM also controls redox homeostasis and inflammation, independently of the DDR. It is
currently unclear which, if any, effector functions of ATM are necessary for drug resistance and metastasis in
NSCLC. Our central hypothesis is that ATM is conditionally activated in late-stage NSCLC as an adaptive
response to therapy and tumor microenvironment (TME) mediated stress. We also propose that inhibiting
ATM using the BBB penetrant ATM kinase inhibitor AZD1390 will help delay or overcome resistance to
standard of care treatments in certain NSCLC patients with metastases in the brain AND other sites. The
premise of this proposal is based on our findings that ATM is activated in disseminated cancer cells from different
models of NSCLC that are resistant to targeted therapy or ICB and that have metastasized to the brain. Moreover,
we have shown that AZD1390 can improve the efficacy of targeted therapy and ICB in these models. Our
mechanistic approach will leverage data-independent mass spectrometry (DIA-MS) to identify context
dependent effectors and markers of ATM kinase activity and AZD1390 response. In Aim 1, we will use models
of Epidermal Growth Factor Receptor mutant (EGFRmut) NSCLC that develop persistence or resistance to the
tyrosine kinase inhibitor (TKI) osimertinib in vivo and test the hypothesis that reactive oxygen species (ROS)
from the TME as well as cell intrinsic ROS induced by targeted therapies, lead to ATM activation. The
requirement for ATM during progression in the brain will be compared to extracranial responses. In Aim 2, we
will identify the mechanism by which ATM regulates tumor cell intrinsic immune evasion using novel
immunogenic mouse models of Kirsten rat sarcoma virus mutant (KRASmut) NSCLCs, which develop brain
metastases with concurrent systemic disease. We will ascertain the requirement for T cells, tumor associated
macrophages, or microglia in mediating the synergistic effects of AZD1390 and ICB, and then corroborate our
findings in human biospecimens, including brain metastasis tissue with matched extra-cranial tumors and liquid
biopsies. Finally, in Aim 3, we will conduct a Phase Ib/II trial to evaluate the feasibility and efficacy of combining
AZD1390 with osimertinib in patients with TKI resistant EGFRmut NSCLC including, but not limited to, cases
with progressing brain metastases. Biopsies from patients that undergo standard of care surgery or that are
enrolled in our trial will be leveraged to identify proteogenomic markers of AZD1390 response.
Completion of the proposed Aims could reveal how to effectively treat extra-cranial tumors as well as brain
metastases and improve the clinical outcomes of NSCLC patients with advanced stage disease.

Public health relevance
PROJECT NARRATIVE Cancers of the lung frequently metastasize into the brain, which significantly diminishes patient survival and quality of life. Our proposal will apply multi-disciplinary approaches with new molecular profiling technologies, culminating with a clinical trial in human patients with the goal of specifically targeting lung cancer cells that have spread to the brain and develop resistance to therapy. By testing new drug combinations that are active in the brain, this project could reveal fundamental new methods of diagnosing and treating lung cancer patients with advanced staged and disease.